HUMATROPE AND LOW DOSE ESTROGEN IN TURNER SYDNROME

This study is assessing low dose estradiol therapy and humatrope in lessening the growth retardation associated with Turner Syndrome. It is supported by Eli Lilly.